Molecular mechanisms regulating formation of diverse stem cell progenitors

ABSTRACT
Stem cell progenitors are essential for fetal and adult wellness. In mammals, the first stem cell progenitors are
established in the embryo shortly after fertilization, as pluripotent and extraembryonic cell types. Pluripotent
cells will become the fetus, while extraembryonic cells will encircle the fetus and direct the formation of crucial
cell types including heart, blood, and brain. The failure to properly execute the molecular programs that first
establish pluripotent and extraembryonic cell types can thus result in catastrophic developmental outcomes.
We aim to understand these molecular programs. The transcription factor OCT4 is known to be essential for
pluripotent cells in the mouse embryo. Intriguingly, we discovered that OCT4 has a second, novel activity:
driving the parallel formation of extraembryonic cells in the embryo. Remarkably, we discovered that
extraembryonic stem cells are induced in parallel to induced pluripotent stem cells during routine somatic cell
reprogramming, indicating that reprogramming mirrors early development more than previously appreciated.
We now understand that OCT4 regulates the expression of distinct transcriptional targets in pluripotent and
extraembryonic cells. However, we do not yet know how OCT4 activity is regulated to enable its cell type-
specific functionalities. The prevailing goal of the proposed studies is to discover how OCT4 activity is
differentially regulated in pluripotent and extraembryonic cells. We will test three non-exclusive models for
modulating OCT4 activity: cell type-specific OCT4 binding partners, cell type-specific OCT4 post-translational
modifications, and cell type-specific chromatin states. Because of the unique experimental advantages
provided by embryos and reprogramming, we integrate studies in each model system to make more rapid
progress than we could using either system alone. Our approach will expose new molecular mechanisms for
ensuring normal embryonic development, for ensuring predictable outcomes during reprogramming, and for
healthy functioning of human cell types that depend on OCT4. The outcomes of our studies will impact clinical
goals of improving human fertility, eradicating birth defects, and devising innovative stem cell models and
therapies.

Public health relevance
PROJECT NARRATIVE We recently discovered that the pluripotency factor OCT4 also induces formation of an important extraembryonic stem cell progenitor during mouse embryogenesis and somatic cell reprogramming. This is important because it reveals a new role for OCT4 and a new mechanism for diversifying stem cell progenitors. This project will identify the mechanisms regulating the activity of OCT4 to enable its two functionalities, ensuring healthy embryogenesis and predictable outcomes for regenerative medicine.